Imaging Core

PROJECT SUMMARY
The Imaging Core of the Center for Cancer and Metabolism (CCM) is the technical service and support core
for CCM project research laboratories and pilot project recipients. The integrated services of the Core range
from the imaging capabilities of simple microscopes to imaging analysis by sophisticated and advanced
imaging methodologies. The Imaging Core personnel assist users to operate the instruments and analyze
imaging data. The Core provides advice for the current PIs in this Center of Biomedical Research Excellence
(COBRE) application to use the Imaging Core for their specific studies. The Imaging Core has provided
tremendous help to the projects in Phase I of COBRE support and will continue to make its services readily
available and easily accessible to all COBRE laboratories in order to generate high quality data. Toward the
goals of providing efficient and high-quality imaging services and of establishing a robust imaging infrastructure
within the CCM, we have added new features and new imaging systems to the Core. Our specific aims are: 1)
to provide project-specific training and consultation for COBRE investigators; 2) to develop and adapt state-of-
the art imaging techniques to enhance the research of early-stage and pilot project investigators; and 3) to
develop and implement new methods, to enhance CCM imaging services and make such services available to
COBRE and non-COBRE users. This Core will provide an easily accessible facility where investigators can
evaluate their tissue and/or cellular samples using various types of imaging systems. Dr. Jianhang Jia, the
Director of the Imaging Core, is a highly productive investigator who has successfully obtained substantial
extramural research support including an NIGMS Maximizing Investigators' Research Award (MIRA) (R35)
award for established investigators that relies extensively on sophisticated imaging capabilities. He has worked
closely with all graduated COBRE PIs, making significant contributions to their successes in obtaining
independent research support. Dr. Jia has guided the development of the four CCM research projects in this
Phase II application, and he will continue to advise CCM investigators on the design of experiments that use
imaging modalities.